Dendritic integration at the retinogeniculate synapse

Project Summary
One of the most remarkable properties of the brain is its ability to compute and integrate information. In the
visual system, processing of visual scenes begins in the eye, where the underlying retinal circuitry segregates
information into 30 – 40 distinct functional channels, each encoding one particular visual feature. Retinal
ganglion cells (RGCs), the output neurons of the retina, relay these signals to downstream visual centers
where they are integrated to mediate perception and drive behavior. The retinogeniculate synapse in the
dorsal lateral geniculate nucleus (dLGN) represents the first connection between the eye and the brain and
has been widely studied across multiple species. A prominent feature of the retinogeniculate synapse is that
retinal inputs have a high propensity to organize into synaptic triads with inhibitory terminals and the
postsynaptic dendrite creating a local circuit for fast feedforward inhibition. Recent studies have
demonstrated that signals from multiple RGC types converge onto thalamocortical (TC) neurons, even at the
level of individual dendrites. The extent of which different RGC types participate in these synaptic triads and
how inhibition shapes integration of information from the retina in the dLGN is poorly understood.
Retinogeniculate triads ensure that excitation and inhibition arrive with high spatiotemporal precision onto
dendritic appendages of TC neurons. The overall goal of this proposal is to understand the function of
retinogeniculate triads in coordinating dendritic integration at the retinogeniculate synapse. Specifically, this
study will address two aims: (1)To assess the functional organization of RGC types into retinogeniculate
triads and (2) To determine how local feedforward inhibition transforms responses in TC dendrites. The
proposed experiments involve high-resolution visualization of synaptic input organization along TC dendrites
and manipulation of activity in presynaptic terminals to understand how incoming visual signals are
integrated across dendritic compartments.
In conducting these experiments, I will learn how to pair optogenetics/chemogenetics with physiological
methods, including patch-clamp electrophysiology and calcium imaging. Additionally, I will receive extensive
training in large-scale data analysis for experiments related to super-resolution microscopy, electron
microscopy, and in vivo calcium imaging. This proposed research will provide unique training that will prepare
me for an independent career in dendritic and sensoryintegration.

Public health relevance
Project Narrative Results from this proposed study will provide insight into how local inhibitory circuits in the form of synaptic triads regulate integration of incoming visual information. Knowledge gained from this proposal will further our understanding on how synaptic input organization can dictate synaptic function. These experiments will provide valuable information on fundamental principles of the nervous system that will help guide therapies for neurodevelopmental disorders resulting in disruption of the excitation-inhibition balance, such as in several forms of autism.